Improving Pediatric Cardiac Arrest Survival and Neurologic Outcome

Project Abstract
Thousands of hospitalized children in the United States die from cardiac arrests each year. Brain injury is
common among survivors. Therefore, new approaches are needed to not only improve survival, but to preserve
brain function of children who suffer a cardiac arrest. Hemodynamic-directed cardiopulmonary resuscitation
(HD-CPR) – where resuscitation is titrated to invasive blood pressure (BP) – has shown promise in animal
models, but its use is not common in clinical practice. Critical limitations for translation may be that optimal
BP targets are unknown. In a recently published, large (n=164), multi-center prospective observational trial,
the investigative team demonstrated that a mean DBP during CPR ≥30 mmHg in children ≥1 year-old was
associated with greater likelihood of survival to hospital discharge compared to lower DBPs (54% vs. 35%,
respectively). In response, the primary objective of this proposal is to evaluate the effect of two different blood
pressure targets (HD-CPRSD vs. HD-CPRHP) on survival, utilizing these thresholds. In addition, because most
children who survive have a neurologic injury following cardiac arrest, the investigators will determine if
different blood pressure strategies have an effect on cerebral blood flow. Concurrently, because not all patients
have invasive monitoring in place at the time of arrest, the investigators will further develop a new indication
for a novel device that can noninvasively quantify blood flow and oxygenation in the brain, laying the
foundation for a paradigm shift in the monitoring and treatment of children before, during, and after a CPR
event, where invasive neuromonitoring is rarely used due to perceived/actual risk. Finally, because improving
cerebral blood flow during CPR cannot completing reverse/mediate neurologic injury initiated by cardiac
arrest, this application will also investigate the role that mitochondria – the cellular engines of our bodies and
key regulators of cellular life/death – play in the development of brain injury post-cardiac arrest to elucidate
potential therapeutic targets; and, based on exciting preliminary data, test a promising, innovative therapeutic
that provides an alternative fuel source to mitochondria to preserve cellular energy production mitigating brain
injury following cardiac arrest. To achieve these objectives, a large animal randomized trial in a porcine model
of pediatric in-hospital cardiac arrest is proposed with the following aims:
• Compare survival and intra-arrest systemic and cerebral hemodynamics between strategy of targeting
threshold blood pressure targets HD-CPRSD to one targeting higher goals HD-CPRHP.
• Among animals surviving 24 hours post-IHCA, compare cerebral mitochondrial dysfunction and reactive
oxygen species, cerebral metabolism, brain imaging, and neuropathology, and neurofunctional outcomes at
24 hours and at 7 days between those treated with HD-CPRSD and HD-CPRHP.
• Evaluate the effectiveness of a cell permeable succinate prodrug – a novel mitochondria-targeted
therapeutic – to improve oxidative phosphorylation and attenuate bioenergetic crisis.

Public health relevance
Project Narrative Pediatric cardiac arrest affects thousands of hospitalized children each year and is associated with poor survival. Even among survivors, new neurological morbidity is common. The objectives of this grant proposal are as follows: 1) to evaluate the survival effect of two different blood pressure strategies (HD-CPRSD vs. HD- CPRHP) during hemodynamic-directed cardiopulmonary resuscitation (HD-CPR); 2) to obtain data on cerebral blood flow and oxygenation, and to validate the use of a noninvasive measures of these cerebral metrics during pediatric cardiac arrest; 3) to elucidate molecular mechanisms that may contribute to long-term cognitive deficits after pediatric cardiac arrest; and 4) to test a promising mitochondria-directed therapy to preserve cellular energy production.